Real-world Assessment of Social Functioning during OUD Treatment: Integrating Reports from Patients and their Concerned Significant Others

PROJECT SUMMARY/ABSTRACT
Opioid use disorder (OUD) continues to be associated with high rates of morbidity and mortality and has a
significant impact on affected individuals, their families, and their communities. Problems related to social
functioning are part of OUD criteria and a wealth of research suggests that individuals with OUD may be prone
to experiencing isolation, loneliness, lack of social support, and poor conflict resolution and problem-solving skills
in interpersonal contexts. Emerging evidence suggests that OUD treatment, particularly behavioral treatments
adjunctive to medications for OUD (MOUD), may improve social functioning and that gains in social functioning
may have beneficial impacts on OUD recovery; however, the specific social functioning metrics that are
associated with positive OUD treatment trajectories are understudied. Further, much of the extant literature has
only examined social functioning from the lens of the patient with OUD, even though reports from concerned
significant others (CSOs) may have valuable predictive utility. The proposed study seeks to address gaps in the
field by examining how affiliative social engagement behaviors, social reward, and social connection change and
are associated with positive OUD treatment outcomes among a sample of 100 patient-CSO dyads. The study
will combine established ecological momentary assessment (EMA) methods with the use of an innovative
smartwatch-based application (i.e., SocialBit) in a single-armed trial to assess both subjective self-reports and
objective measurements of social functioning from patients with OUD and a non-substance using CSO. Aim 1
will determine how patient-reported and CSO-reported social behaviors, social reward, and social connection
change during OUD treatment; Aim 2 will identify if patient-reported and CSO-reported social behaviors, social
reward, and social connection predict MOUD adherence and opioid craving; Exploratory Aim 3 will validate the
use of SocialBit for assessing social connection in an OUD treatment sample. Drs. Jarnecke and Tomko (MPIs)
have assembled a team of renowned investigators with expertise in OUD, social functioning, dyadic data, EMA
methods, and the translation of clinical data into novel therapeutics. There is an urgent need to address how
social functioning contributes to OUD and opioid overdose, and to take a “whole person” approach to treatment.
Findings have strong potential to inform future precision-medicine approaches focused on the dual targets of
OUD and social functioning.

Public health relevance
PROJECT NARRATIVE d Problems with social functioning are core to opioid use disorder (OUD), though specific, modifiable social functioning targets and how they relate to OUD treatment outcomes are poorly understood. The proposed study will utilize both dyadic data and innovative ecological momentary assessment methods to examine associations between specific social functioning metrics and OUD treatment outcomes. Findings from this study will inform future precision-medicine approaches for people with OUD, a population in significant need of enhanced treatment approaches to combat opioid morbidity and mortality.